Developing Hepatoselective Hepatitis B Therapeutic Dihydroquinolizinone (DHQ) Molecules with Better Safety Profiles for Efficient HBsAg Reduction

ABSTRACT
Inhibition of the host RNA quality control enzymes, PAPD5 & 7, with a Dihydroquinolizinone RG-
7834 (DHQ-1), a small molecule, rapidly reduces hepatitis B virus (HBV) RNA levels, and hence
almost all viral gene products, including HBsAg. This represents an entirely new category of HBV
antivirals. But observation of neurotoxicity of DHQ-1 limits the degree of systemic use for
management of chronic hepatitis B (CHB). This side effect can be minimized or eliminated by
producing liver selective and CNS refractory DHQ antivirals. We have designed and synthesized
a novel series of bis-carboxylic acid based DHQ derivatives that are outside current patent
descriptions. They have organic anion transporting polypeptide (OATP) substrate properties,
which facilitated selective distribution of the compounds to the therapeutic site of action (liver)
relative to the blood stream. These eﬀorts led to the discovery of an early lead DHQ-E-OH (3),
which is potent in both biochemical and cellular assays, while demonstrating considerable safety
improvements such as low blood-brain barrier (BBB) penetration potential and higher liver
selectivity over plasma (liver/plasma ratio is 37.8 in PK study) in contrast to DHQ-1. However, the
early lead 3 was found to be absorbed via oral administration at a low level, likely due to its low
lipophilicity. This Phase I proposal is therefore to build on this discovery and determine if even
more efficacious DHQ derivatives with more balanced hepatoselectivity and permeability, can be
produced, so that they retain potent inhibition of PAPD5 & 7 and HBsAg with increased intestinal
absorption while maintaining the good liver targeting selectivity and low BBB penetration risk.
Through an iterative structure-ADME optimization, the allowed window for the permeability of this
series of compounds will be investigated. The new compounds will be tested in in vitro assays
and in vivo pharmacodynamic models for their ability to reduce HBsAg, blood-brain barrier
penetration, maintain high liver tropism and liver/plasma distribution ratios, and most importantly,
increase the concentration and residency time in liver but not causing liver and neurite formation
toxicity. Compounds that meet these specific criteria will be advanced to the STTR Phase II
studies of efficacy and toxicity.

Public health relevance
Project Narrative Hepatitis B continues to be the world’s leading cause of hepatocellular carcinoma. A vaccine is preventive, and although there are therapies, non are curative and even after ten years of use, reduce mortality by only 50-60%. New effective medicines are urgently needed. This is a proposal to produce a drug that can be a breakthrough approach.